Administrative Core

ADMINISTRATIVE CORE ABSTRACT
The Administrative Core (AC) is responsible for the overall management and oversight of the Rare Disease
Clinical Research Consortia (RDCRC) including developing and implementing policies and procedures,
allocating funds, and integrating activities across the 16 sites. The functions of AC include coordinating
communication among the sites and integrating participating researchers into a cohesive environment.
Additionally, the AC will serve as the point of coordination with the Rare Disease Clinical Research Network
(RDCRN) via the Data Management and Coordinating Center (DMCC) and the patient and stakeholder
communities through the National Urea Cycle Disorders Foundation. The AC will include a Clinical Team Liaison
who will ensure a mutually supportive interaction between the investigators conducting the clinical research
projects. The AC will also include an Administrative Coordinator who will be responsible for assisting the Urea
Cycle Disorders Consortium (UCDC) PIs with day-to-day administration and program coordination activities. The
AC will coordinate and support RDCRN-wide efforts to develop and monitor best practices for clinical and
research data handling and use, including the use of common data elements. The AC will maintain a website to
inform patients, families, clinicians, researchers, and the general public about ongoing clinical studies in the
consortium, resources provided by the DMCC, career enhancement opportunities in the Career Enhancement
Core and relevant results from the research studies. The overall responsibilities of the of the AC are described
in the following categories:
Administration: (a) Overall vision, strategic planning, evaluation and coordination of all UCDC activities; (b)
Budget management and resource allocation; (c) Review and supervision of pilot projects; and (d) Organizing
Executive Committee, faculty and staff, and External Advisory Committee meetings.
Research: (a) Assure efficiency and cost-effectiveness of research projects; and (b) Foster and promote
translational research and transdisciplinary collaborations among investigators at the participating institutions.
Career Enhancement and Education: (a) Provide mentoring, administrative support and supervision for the
career development program; (b) Attract and recruit junior investigators to the UCDC; (c) Facilitate the work of
mentors within our training program; and (d) Support and oversee career development activities (grant writing,
research projects, presentations, publications).
Dissemination: Communicate our research findings by (a) Maintaining a robust website with information about
ongoing research, and ways to participate in specific clinical trials and educational activities; b) Providing
webcasts and archives on the website of the R25 lectures/seminars; and c) Promoting scientific publications of
UCDC investigators.